ACTIVATION OF SPERMATOGENIC RECOVERY AFTER TOXIC INSULT

Exposure of men to certain environmental, occupational, and medical toxicants may result in prolonged oligoor azoospermia. Occasionally spermatogenesis recovers after years of azoospermia indicating that some stem (type A) spermatogonia survived but their differentiation was limited. This suggests that disruption of spermatogonial differentiation may be responsible for the failure of spermatogenesis to recover following exposure. This hypothesis will be tested in rats exposed to reproductive toxicants by modulating spermatogonial differentiation using hormones and identifying molecular changes associated with the stimulation of recovery. Radiation and dibromochloropropane (DBCP) will be used as the toxicants, because of the precision of delivery and relevance as an environmental and occupational reproductive toxicant, respectively. Radiation (and DBCP, based on preliminary data) produces in rats the loss of all differentiating spermatogenic cells despite the presence of proliferating A spermatogonia. The causes of failure of spermatogonial differentiation will be characterized as follows. The role of hormonal changes will be examined by minimizing them using unilateral irradiation. The possibility that hormone receptor levels are reduced will be examined. To determine whether the defect is in spermatogonia or stromal cells, cell transplantation techniques will be employed. The recovery of spermatogenesis can be stimulated by gonadotropin-releasing hormone (GnRH) agonist treatment given immediately after irradiation; whether the stimulation is a result of altered levels of androgens or gonadotropins will be determined. Further studies will be performed to determine if GnRH can be used to induce spormatogonial differentiation after regression has occurred. GnRH-stimulation of spermatogenic recovery, or alternative models that result in spontaneous spermatogonial differentiation and recovery of spormatogenesis from A spormatogonia, will be used to identify molecules regulating differentiation of spermatogonia. Patterns of protein or mRNA levels in testes in which A spormatogonia do not differentiate and those in which differentiation occurs (hormone-stimulated recovery, alternative models, untreated) will be compared to identify genes whose expression correlates with spermatogonial differentiation. This study should define factors that not only modulate spormatogenic recovery after toxicant exposure but also regulate normal spormatogonial differentiation. Hormones or other factors identified in this project might be used as intervention to enhance recovery of fertility in men following toxicant exposure, cancer therapy, and in some cases of idiopathic infertility.